Healthy Youth Development Prevention Research Center

DESCRIPTION (provided by applicant): The mission of the Healthy Youth Development Prevention Research Center (UMN PRC) is to collaborate with health departments, related agencies and community partners to develop and disseminate actionable knowledge and practices that promote healthy development and health equity among all young people. Our specific aims, reflected in our unit-specific work plans, include the use of interdisciplinary research, training, community education, TA, capacity-building, strategic communications, and evaluations to build health, competence, and capacity throughout the second decade of life and beyond, and to build capacity in partners working with and on behalf of young people. Our long-term objectives focus on expansion of scientific knowledge and increased use of evidence-based public health programs that advances the national health agenda as reflected in Healthy People 2020's adolescent-focused goals (5 of 7 priority areas), promotes health equity as articulated in the National Prevention Strategy, and addresses CDC adolescent-related Winnable Battles (i.e., reproductive health). The UMN PRC core project, Partnering for Healthy Student Outcomes (PHSO) is a comparative study of the relative effectiveness of a school-based, social-emotional learning (SEL) prevention program for students attending culturally diverse, economically disadvantaged middle schools in the Minneapolis-St. Paul, MN metro area. Our primary research question is: Will a multi-year, school-based prevention program, infused with professional development (PD) aimed at increasing the capacity of middle school teacher teams to engage their students in learning, yield changes in middle school students' health risk behaviors and academic outcomes that exceed outcomes from a school-based student-focused prevention program alone? The research has two primary aims: Primary Aim 1: Conduct a pilot study to determine the feasibility and acceptability of a school-based, SEL+PD program (Positive Action plus teacher-team professional development and support) designed to reduce health risk behaviors (violence, bullying, substance use, sexual risk behaviors) and increase academic achievement among middle school students; and Primary Aim 2: Implement a SEL plus teacher-team professional development program and evaluate its effectiveness on student outcomes compared to a SEL program alone. We will evaluate the two conditions in a matched pairs, randomized trial involving approximately 840 students in 4 urban middle level schools across 3 school years.

Public health relevance
I. INFRASTRUCTURE AND ADMINISTRATION (Index of acronyms in Appendices Table of Contents) A. Mission, Goals and Priorities. Minnesota is a prime arena for addressing social inequities in health. Rapidly changing demographic composition has contributed new strengths as well as challenges to our health, education, and social service systems. MN leads in East African, Latino and SE Asian immigration; Minneapolis has the second largest urban American Indian population in the US. Our communities of color are relatively young in terms of percentage of families with children, and particularly in Minneapolis and St. Paul, health disparities are intermingled with economic distress and social segregation. The stark reality confronting our communities and our systems of care is the deepening need for partnerships that meld community experience with scholarship and public health (PH) practice-based knowledge. We believe, in the words of the Lancet International Advisory Group on Adolescent Health, that "...failure to invest in the second decade of life, despite the availability of proven and promising prevention and health promotion strategies, will jeopardize earlier investments in health, substantially erode the quality and length of human life, and escalate human suffering, inequity, and social instability."1 The University of Minnesota Healthy Youth Development Prevention Research Center (UMN PRC) is dedicated to nurturing partnerships that will co-create the fusion of knowing and doing through its core mission: through collaboration with health departments, related agencies & community partnerships, develop and disseminate actionable knowledge and practices that promote healthy development & health equity among all young people, and, in so doing, advance adolescent-focused Healthy People 2020 (HP 2020) goals, elements of the National Prevention Strategy, and CDC Winnable Battles, particularly reproductive health. B. Organizational Structure and Linkages. Initially funded by the CDC in 1996 as the National Teen Pregnancy Prevention Research Center, UMN PRC is embedded in an institutional context highly conducive to achieving its core mission, goals and objectives, and leveraging complementary resources that expands its reach and impact. As in Org Charts (App D), UMN PRC is part of an Academic Health Center (AHC) that includes the Schools of Medicine, Nursing, Public Health, and the UMN's CTSA. UMN PRC faculty/staff are appointed in these AHC schools along with the College of Education & Human Development. The AHC is under the direct authority of the UMN President, whose community engagement activities are conducted under the auspices of the Office of Public Engagement to which UMN PRC members play an ongoing advisory role. Likewise, the UMN CTSA partners with the PRC to strengthen its own inter-collegiate community engagement portfolio of applied public health research, training, outreach and advocacy. UMN PRC is located within the Division of General Pediatrics & Adolescent Health (DOGPAH), with its 35- year history and expertise in adolescent health research and translation, training, TA, community partnerships, strategic communications, and dissemination of evidence to promote effective programs, policy and public health practice. At its inception, UMN PRC capitalized on this experience through immediate formation of a Community Advisory Network, and involvement of community partners, health departments and related agencies in the crafting of our earliest core research focused on preventing teen pregnancy and sexual risk behaviors (Prime Time). This early research evolved into school and clinic-based interventions that engaged community members, educators and PH professionals in youth-development strategies to prevent teen pregnancy, violence involvement, and school dropout. Our earliest intra- and inter-collegiate linkages with the Konopka Institute for Best Practices in Adolescent Health (and its State Adolescent Health Resource Center that provides TA and consultation to the nation's network of State Adolescent Health Coordinators), the Center for Adolescent Nursing (with its extensive history of adolescent health research and preparation of the scholarly and practice workforce), and the School of Public Health, nurtured the early development of an interdisciplinary faculty and staff, linked across academic units, with a shared commitment to prevention science, community engagement, applied research and its translation into action. C. Staffing Plan. UMN PRC 2014-2019 will be guided by a Leadership Team comprised of Director Resnick, Deputy Director Sieving, and Team Leaders: Oliphant (Community), Shea (Communications), Jordan (Training), Shlafer (Evaluation) and McMorris (Research). The UMN PRC Org Chart (App D) depicts the Leadership Team that will provide overall direction to the PRC, the interdisciplinary teams for each unit, their key activities, and reporting lines within the broader context of the Division. We developed this organizational structure in our initial funding cycle, honed and refined over time, recognizing that a Leadership Team that includes CAN co-chairs (nominated & elected as per CAN by-laws) is essential to a PRC that is nimble and responsive to priorities and concerns from health departments and other community partners. The UMN PRC led the March 2008 PRC national network pre-conference “Structured for Success” that explicated the PRC network’s experiences with varying infrastructure arrangements. With the goal of enhancing each PRC's capacity to increase its own effectiveness through infrastructure modification and improvements, this marked the 1st time in the history of the network that PRC directors/representatives shared with each other the various infrastructure arrangements crosscutting the national network. D. Leveraged Resources and Institutional Commitments. Since its inception, UMN PRC has garnered approximately $21,000,000 in research and training grants, PRC Special Interest Projects, foundation grants, contracts and external sales. Documented in Letters of Support and shown in the UMN Org Relationships Chart, the UMN institutional commitment in this competitive renewal application equals approximately $365,000, i.e., annual match dollars for each of 5 years of the project period from the Office of the Vice President for Research ($10,000), the AHC ($20,000), Department of Pediatrics ($20,000), CTSA (15% Training Team Leader Jordan salary and fringe support, ~$23,000), and the Division of General Pediatrics & Adolescent Health (office space, administrative, financial and technological support). E. Qualifications and History of PRC Director. On faculty since 1981, Michael Resnick, PhD, Professor of Pediatrics, Nursing, and Public Health, holds the Konopka Chair in Adolescent Health & Development. He is the founding PD/PI (1996) of the UMN PRC. With colleagues, his work has had a transformative impact on shaping the field of adolescent health in the US and globally. Beginning in the 1980s, under his leadership of the National Adolescent Health Resource Center (funded by MCHB/HRSA/DHHS), the MN Adolescent Health Survey and the subsequent American Indian Adolescent Health Survey (the largest survey of American Indian and Alaskan Native youth ever undertaken at the time) formed the basis for the CDC in creating the National Youth Risk Behavior Survey (YRBS). Resnick served as a consultant to the CDC as the YRBS was being developed, which today, is implemented in nearly every state across the country. His federal congressional testimony on the findings of the Indian Adolescent Health Survey helped propel Congress to authorize more than $30 million for adolescent mental health for young people on reservations, a 1st in the history of the Indian Health Service. Resnick was also invited under two presidential administrations to be a keynote speaker at White House conferences on youth. It is this interweaving of research and the translation of research to improve the health and well-being of young people that has characterized his career. It is also because of his growing reputation that in the mid 1990s he was invited to be a Co-PI on the National Longitudinal Study of Adolescent Health (Add Health) where, leading the MN team he had lead responsibility for crafting the initial adolescent health survey component of that study. That landmark research was released in 1997 with Resnick as lead author in JAMA. 2 This seminal article has been cited more than nearly any other publication in the field of adolescent health and led to widespread prominence of the theme that has epitomized his research: the influence of connectedness on adolescent health and well-being. Resnick's work has had a profound impact on the field of adolescent health, ranging from our own federal Office of Adolescent Health to the work of transnational institutions such as the World Health Organization, the Pan American Health Organization, UNICEF, and more recently, the Lancet International Advisory Group on Adolescent Health, where we see adoption of the healthy youth development paradigm that flows directly from Resnick's work. In this area of research and research translation, no measures are more frequently used, than those developed by Resnick with his interdisciplinary team at UMN. The use of this research on how to best advance health equity in young people, assuring their ability to enter into rapidly changing social contexts and a very complex global economy, embodies what Resnick has long defined as a goal of his career: to use science, translation, dissemination and evidence-based advocacy to assure that we regard adolescents as whole human beings in the context of family, peers, school and community, not as a simple set of risk indicators. It is his ability to translate that research that has resulted in global impact. He has been invited to speak at policy and research forums in Australia, New Zealand, Canada, Portugal, Britain, Malaysia, Iceland, Germany, Switzerland, and Turkey. And because of his international reputation he has attracted fellows and trainees from not only across the United States but from Spain, Australia, New Zealand, Ghana, China, Barbados, Argentina, Uruguay, Israel, and Canada, seeking to learn how to conduct research into healthy youth development and to translate that work to set public health priorities and policies that benefit youth. Resnick has been PI or Co-I on numerous federal and foundation research grants focusing on health and risk behaviors, resiliency and protective factors in the lives of young people, with emphasis on issues related to adolescent sexual behaviors, teen pregnancy, violence and school drop-out. He has been PI on $17.7 million in external grants (NIH, CDC, MCHB, foundations) and co- PI/co-author on an additional $8.7 million in external grants (counting awards of >$100,000). He has 177 peer reviewed journal articles, book chapters, reviews, and monographs, many reflecting his active mentoring of newer faculty, fellows, and staff. He has served as a consultant/reviewer for WHO, NSF, CDC, NIH, the Society for Adolescent Health & Medicine, the Guttmacher Institute, the Natl Campaign to Prevent Teen & Unplanned Pregnancy, and several international research councils. He has received 4 outstanding teaching and research awards. His PRC commitment will be 25%, supported by a combination of PRC funds and resources from his Endowed Chair and match dollars. F. Multidisciplinary Faculty and Staff with Demonstrated Experience. The UMN Org Chart shows the academic appointments and inter-linkages of faculty and staff across the Schools of Medicine, Nursing, and Public Health, and within our Division (DOGPAH) that create the group comprising UMN PRC. A particular strength of this team is its intercollegiate, interdisciplinary composition, years of continuity in terms of working relationships, and extensive experience in partnering with state, county and local health departments, related agencies, and an array of community partners that share a commitment to nurturing healthy adolescent development and the promotion of health equity among all young people. A table in Facilities & Resources lists the PRC members, their areas of expertise and those who hold 1o and 2o appointments in AHC schools and elsewhere at UMN. Our embeddedness in collaborative networks further flows from a long series of core, community-partnered PRC projects that link scholarship, practice and dissemination of evidence with our broader constituents and partners, foremost among them - state and local health departments, schools and youth-serving agencies. As noted in a table in Facilities & Resources, PRC members are partnered with national, regional, state and local collaborating organizations in a variety of capacities: research, TA, training, evaluation, program and policy development, enactment, and diffusion. These relationships provide the basis for our proposed scope of work, designed to address adolescent-focused national health goals, elements of the National Prevention Strategy, and the CDC's Winnable Battles. G. Ongoing-prevention Projects & Activities. UMN PRC members are engaged in a wide array of prevention/health promotion activities supported by a diverse portfolio of funding that reflects our interdisciplinary composition and well-established partnerships. These research, training and dissemination activities will underpin much of UMN PRC's plan for activities over the next 5 years, involving state, county and local departments of health, related agencies, community organizations and scholarly partners that share a commitment to healthy youth development, the dual strategy of reducing risk while enhancing protective factors and capacity in the lives of young people, and enhancing health equity that promotes positive life trajectories for youth, particular those living in challenging social environments. UMN PRC On-going Prevention Projects and Activities Supported by non-PRC Funds (alphabetically listed) Project / Activity Award Type Funding Source Total Award Funding Dates College Resources and Sexual Health Research MCHB, HRSA $706,293 2010-14 Doula Support for Pregnant Jailed Women Research UMN Prog Hlth Dispar $25,000 2013-13 Evaluation of a Restorative Justice Program for Youth Research MN Dept Public Safety $53,872 2010-13 Evaluation of Big Brothers Big Sisters School-Based Mentoring Program Research OJJDP, Dept of Justice $239,978 2012-15 Interdisciplinary Research Training in Primary Care Training BHPr, HRSA $2,267,867 2012-17 Leadership Education in Adolescent Health Training MCHB, HRSA $1,893,725 2012-17 MN Com Networks Ctr for Eliminating CA Disp; Outreach, Res, Training Center NIH $4,618,891 2010-15 MN Partnership for School Connectedness Research IES, US Dept of Ed $1,490,000 2010-14 Observations of Children's Visits with Jailed Parents Research UMN OVPR Grant-in-Aid $37,033 2013-14 Project EAT-IV: Eating and Activity in Adolescents & Young Adults (R01) Research NIDDK, NIH $2,973,317 2013-17 Promoting Hlth & Pos Youth Devel for Somali, Latino, & Hmong Youth Research Natl Inst Minority Hlth,NIH $1,102,231 2013-16 Reducing Stigma, Promot Resilience: Pop Hlth Interv for LGBTQ Youth Research Canadian Inst of Hlth Res $399,225 2012-17 State Adolescent Health Resource Center Center MCHB, HRSA $1,500,000 2009-14 Transitions in Adult Health Care for Youth with Mobility Limitations Research NCBD, CDC $2,375,000 2009-14 UMN Knowledge to Practice in Adolescent Health Training MCHB, HRSA $289,787 2013-16 Understanding Dispar in Obesity & Weight Behaviors by Sexual Identity Research NICHD, NIH $230,187 2012-14 Using Developmentally Appropriate Educational Materials to Improve Child Behavioral Health & Family Relationships with Jailed Parents Research UW-Madison/UMN CTSA CHEA $149,805 2013-15 II. COMMUNITY ENGAGEMENT, PARTNERSHIPS, AND TECHNICAL ASSISTANCE A. Collaboration with Community Health Departments and Other Stakeholders. UMN PRC has an extensive history of collaborating with and providing technical assistance (TA) to local, county and state departments of health. As shown in the Work Plan, these ties will continue as we engage in work that connects with community and increases the capacity of the PH workforce, i.e., we will capitalize on these relationships as evidenced through Letters of Support. Community Advisory Network: Headed by Team Leader Oliphant, UMN PRC will utilize the expertise of our Community Advisory Network (CAN). Members of CAN are professionals who have broad expertise in community-based health issues with young people and are employed by PH departments, departments of education, and community-based non-profits. Half of the current members work in city, county and state public health departments thereby strengthening the CAN-UMN PRC connection to public health. CAN advises on various aspects of UMN PRC, including the core research project, community engagement efforts, PH policies, training priorities, and dissemination strategies. Also, CAN provides invaluable guidance on accessing youth-serving professionals, such as nurse practitioners and physicians, teachers, and other public health professionals and will continue to advise on best means for reaching target populations and ensuring greater reach and impact of Center activities. Past examples of CAN involvement include advising on dissemination of the state's policy plan for teen pregnancy prevention, development of topics for training in the Summer Institute, and advising on the core research projects such as assessing the need of out-of-school youth. Letters of Support detail activities, roles and responsibilities, and partnerships goals for 2014-19. Led by 2 co-chairs (elected by the whole body of the CAN to serve 2-year terms), the entire CAN meets quarterly with additional ad hoc meetings as needed; co-chairs also participate in monthly Leadership Team meetings. Co-chairs and all CAN members fulfill duties as outlined by the UMN PRC's CAN job descriptions, rules/policies, and community engagement agreement, all created and approved by CAN (App D). A bi- monthly electronic newsletter assures communication with CAN, the Youth Advisory Board (described below), and local, state and national partners. UMN PRC co-chairs have always actively engaged in the National Community Committee (NCC), serving as chairs or members of the Oral Health Special Interest Group, Policies & Procedures, and Fund Development. Oliphant and at least one co-chair have regularly attended all NCC activities and participate in NCC monthly telephone calls. Oliphant has the trust of CAN and extensive connections to community members, including UMN PRC's target populations. A founding member of the now highly organized NCC, Oliphant has led UMN PRC's CAN since its inception. Youth Advisory Board. UMN PRC will build on its existing Division's Youth Advisory Board (YAB). YAB currently consists of 8 adolescents and young adults (ages 14-21 yrs) who have been trained on adolescent health issues, including teaching interviewing skills to health providers. YAB will be expanded to include 3 youth who have been participating as peer educators in our current PRC core Latino teen pregnancy prevention research project. YAB members are paid on an hourly basis with PRC match funding. Guided by Oliphant, YAB will follow a Youth-on-Boards training model for its monthly meetings designed to advise on various UMN PRC activities. One YAB member elected by YAB will participate in CAN and PRC Leadership Team meetings. In addition, YAB members will be engaged in community activities, providing TA to health departments for the development of programming as well as providing training and feedback around interviewing skills to medical and oral health professionals. Thus, YAB members will serve as technical experts and teachers to practitioners who need training in best practices for interviewing adolescents on specific topics related to the HP 2020 goals identified in the Community Engagement Work Plan. B. Community Support and Engagement. UMN PRC will collaborate and provide TA to several departments of health and education in its proposed scope of work, to commence in Fall 2014, including: 1. Oral Health and HPV-An Adolescent Health Initiative: The Minnesota Department of Health (MDH) and UMN PRC will collaborate to develop a best-practice approach for MN dentists and oral health providers to increase the awareness of Human Papillomavirus (HPV) and the link to oropharyngeal cancer (OPC). MDH's Oral Health Program and UMN PRC will develop a module for interviewing skills for dental health providers that focuses on HPV, HPV vaccine and adolescent-friendly services, especially in school settings. This work is an extension of the MDH Oral Health State Plan and the PRC's NCC Oral Health Work Group with approaches based on CDC's recommendations for approaching high-risk groups for HPV-associated OPCs and current trends in the incidence of HPV-positive OPCs. YAB members will provide direction on module development and teach the module to oral healthcare providers. Sparked by conversations with the Natl Oral Health Alliance, NCC, and MDH, this novel approach of using adolescents to teach oral health providers is the 1st of its kind. Key stakeholders include the MN Oral Health Program and MDH Center for Health Promotion. Under the director's leadership, we will have access to the statewide network of dental providers and entry into annual conferences of oral health providers to teach the new module. 2. Adolescent Health Clinics Standards of Care and MN's DASH HIV Grant: Hennepin County (which includes Minneapolis) Human Services and Public Health Department efforts to standardize clinical care for adolescents are a systems-level innovation critical for improved adolescent sexual health outcomes. The standards align with federal-level initiatives in the Office of Adolescent Health, CDC's Divs. of Reproductive Health and Adolescent & School Health (DASH) that emphasize the use of standards-based approaches. We will partner with Hennepin County, MDH and MDE staff funded by CDC DASH and the Natl Network of State Adolescent Health Coordinators with the State Adolescent Health Resource Center (SAHRC) to expanded adoption of clinical standards. This partnership will target new Hennepin County clinics, statewide clinics in school districts targeted through the DASH grant, and nationally, clinics in other states, via the training of State Adolescent Health Coordinators involved in sexual health programs. The partnership will leverage diffusion of innovation strategies to accomplish this goal: segmenting audiences based on adoption and thought-leader status, identifying and promoting the relative advantages of adoption, and addressing compatibility, complexity and trial-ability. These will be promoted via 1) applied communications strategies and products (UMN PRC and Hennepin County will co-create a tool kit); 2) experiential training facilitated by the YAB that will offer clinics real-world experience effectively engaging adolescents; and 3) through inter- personal interactions and relationships, likely accomplished through the formation of a national Collaborative Innovation Network that will allow partners to directly support one another. We regularly partner with SAHRC to support state PH department collaborations to improve systems approaches to adolescent health. 3. MN Chlamydia Partnership (MCP): MDH identified chlamydia as a leading cause of morbidity in MN. Seeking an innovative strategy for its prevention and control, the STD Clinical Specialist Infertility Prevention Project Coordinator (MDH STD and HIV Section) and key stakeholder has requested the UMN PRC to provide TA on future MCP activities. Specifically, through monthly planning meetings and in-the-field TA, we will collaborate on models of care and dissemination of best practices for chlamydia control. These approaches are grounded in the MN State Plan for Chlamydia Prevention developed in a current partnership between MDH and UMN PRC. We will work collaboratively both locally and in greater Minnesota to provide county and local public health as well as community-based health non-profits on non-traditional approaches to the prevention and control of this sexually transmitted disease as outlined in the MN State Plan. 4. Minneapolis Urban Initiative for Reproductive Health: UMN PRC and the Minneapolis Urban Initiative for Reproductive Health under the guidance of key stakeholder, Minneapolis Health Department, will collaborate on development of an innovative model to provide sexual health education to students along with their teachers and coaches in this large urban school district. We will provide TA on implementation of evidence-based sexual health curricula in all 6-8th grade classrooms in the district, as well as in the district's charter and alternative schools. UMN PRC will also provide leadership in development of a program designed to assist coaches in preventing sexual bullying within school sports teams and among team members. 5. Minneapolis Blueprint for Youth Violence Prevention: Minneapolis and its health department are widely-recognized for ground-breaking work in implementing a comprehensive, multi-sectorial plan to prevent youth violence: Blueprint for Action: Preventing Youth Violence. As one of a select group of cities invited to join the Urban Networks to Increase Thriving Youth (UNITY) through a CDC-funded cooperative agreement, Minneapolis promotes collaboration across public and private sectors and adoption of a comprehensive approaches to violence prevention. True to a PH model, the Blueprint lays out 1o, 2o, and 3o prevention goals along with 34 action steps to reduce and prevent youth violence. An executive committee including PRC, government, nonprofit, business and youth representation provides oversight. 6. It's That Easy: It's That Easy (ITE) offers parent educators with the training and tools needed to empower parents to connect with their children, share family values, and engage in conversations about sexuality and relationships. ITE is a train-the-trainer model for youth-serving organizations and health/education departments in urban and rural areas as well as culturally-specific groups, e.g., tribal nations. Co-sponsors are MDH, MDE, and TeenWise MN, a statewide non-profit for teen pregnancy prevention. We will assist in expanding an ITE dissemination plan and serve as content experts to curriculum and website development. 7. Diffusion of Innovation with State Adolescent Health Resource Center (SAHRC): Given our co- location with SAHRC, we are uniquely poised to promote innovative models of partnership with local and state health departments reaching national audiences. SAHRC (described in Letter of Support) provides TA to the nation’s adolescent health staff in state health departments and serves as facilitator for the National Network of State Adolescent Health Coordinators - the membership organization for all state adolescent health coordinators. Recognizing that many UMN PRC community-based projects align well with work underway in other states, UMN PRC will partner with SAHRC to 1) disseminate relevant, highly applied evidence; 2) frame information for adoption of innovation by highlighting advantages and compatibility with existing values and practices; 3) facilitate adoption by engaging adolescent health coordinator networks, identifying an avant-garde of early adopters, and providing them with strategic TA for piloting of innovations. III. COMMUNICATION AND DISSEMINATION A. Infrastructure for Communication and Dissemination. UMN PRC offers an infrastructure of resources and personnel to support communication and dissemination activities with the expertise and capacity to translate research findings and evidence-based practices to various audiences while aligning with diffusion of innovation practices. Since its inception in 1996, UMN PRC has prioritized communications/dissemination - most notably by Resnick, UMN PRC Director (in conjunction with former Division Director, R. Blum), whose dissemination vision included landmark analyses of the National Longitudinal Study of Adolescent Health and translation of these research findings into a monograph series (supported by the Robert Wood Johnson Foundation) for specific audience segments (education, health care, parent/family support professionals) as well as for general public audiences. Dissemination strategies also included partnership with a recognized PR firm (Burness Communications) that resulted in legislative and national press briefings. Resnick has elevated this priority by hiring Shea, Communications Team Leader, a marketing and communications professional with >20 years of communications experience in both hi-tech advertising executive and community/academic settings. Shea directs all PRC communications activities, sets strategy, framing and messaging direction, writes copy and handles graphic design assignments. Shea's expertise is sought by local, state, and national partners and she is frequently asked to consult with adolescent health professionals and organizations. Shea also is recognized locally for her work on state sexual health plans targeting policy and systems changes including A Work in Progress: Building a Minnesota State Plan for Teen Pregnancy Prevention and Parenting (2003) and Recommendations for Action from the UMN Chlamydia Partnership - A Special Report (2012). Shea and Resnick's work is conducted in collaboration with and informed by UMN PRC members and community partners (examples below). External vendors with expertise in graphic design, PR/media relations, video production and social media strategy/production enhance UMN PRC's communications capacity. Given the scope of proposed communications objectives, a .6 FTE will be added to current staff FTE. Communications capacity is also supported by the UMN which offers a wealth of communications related resources including the AHC and University Relations PR and communications staff, AHC computer technical support, printing and video production capabilities, website design and content management as well as a host of collaboration (e.g. the Communicators Forum) and training (social media; web technologies) opportunities. B. Website. UMN PRC has the capacity, expertise and technical support to further develop and maintain a UMN PRC website. The web infrastructure is supported through the AHC which provides consultants and an easy-to-use content management system, enabling the PRC to maintain the site locally. UMN has recently migrated to a suite of Google-powered communication and collaboration tools and, through search engine optimization, delivers highly ranked Google search results. C. Communications Plan. UMN PRC will develop a center-wide communications plan, including 5-year goals, objectives, and activities, that integrates communication activities into research, training, evaluation, and community activities. In the past PRC funding cycle, we created communications plans for partner organizations: Hennepin County, the UMN Chlamydia Partnership, Public Health departments in Kandiyohi County and the city of Worthington and Iowa's Youth Development Initiative. The formal UMN PRC Communications plan will be developed in collaboration with PRC center and core research project faculty and staff, CAN, community partners, local and national public health departments as well as advisors fr...